The Role of Acetyl-CoA Metabolism in Epigenetic Regulation of Myofibroblast Differentiation

PROJECT SUMMARY/ABSTRACT
A common feature of heart failure (HF) is excessive extracellular matrix deposition by a specialized and
differentiated fibroblast population, known as myofibroblasts, in response to cardiac injury. While myofibroblasts
help to maintain the structural integrity of the injured heart and prevent ventricular wall rupture, persistence of
myofibroblasts results in excessive fibrosis and subsequent cardiac decompensation. Therefore, identifying
molecular mechanisms of myofibroblast differentiation in cardiac fibrosis could yield novel clinical targets to delay
or reverse the development of HF. Recent evidence suggests metabolism may drive cellular differentiation
through the modulation of epigenetic-modifying enzymes that enhance or silence genes associated with cellular
differentiation. Altered metabolism changes the concentration of metabolites that act as substrates for
epigenetically modifying enzymes, such as the changing levels of acetyl-CoA that alter the activity of histone
acetyltransferases (HAT). Our preliminary data indicate that increased glycolytic rate is a key feature driving
myofibroblast differentiation. We identified metabolic regulation of histone demethylation as a feature of
myofibroblast differentiation and we now turn our sights to histone acetylation as an epigenetic modification
permissive of myofibroblast gene expression. This proposal hypothesizes that increased acetyl-CoA
biosynthesis is necessary for histone lysine acetylation by HATs during differentiation for the transcriptional
activation of the myofibroblast gene program. This study seeks to identify novel therapeutic targets to mitigate
the consequences of fibrosis in HF.

Public health relevance
PROJECT NARRATIVE There is estimated to be 5.7 million adults in the US suffering from heart failure (HF), representing a significant health care burden for the nation. The progressive cardiac fibrosis and dysfunction seen in HF involves myofibroblast differentiation, with recent data showing myofibroblast differentiation to be driven by discrete changes in fibroblast metabolism. Understanding metabolic processes involved in myofibroblast differentiation will expand the application of new medicines that modulate these processes and ultimately lessen the burden of HF.